CORE--RESEARCH CAREER AND DEVELOPMENT

The UTMB OAIC will promote development of the next generation of geriatric/gerontologic research leaders through direct financial support for salary and travel, structured mentoring, participation in interdisciplinary conferences, other didactic training, networking activities, and access to infrastructure support from the UTMB OIAIC, and other OAICs as appropriate. Specific aims of the RCDC are to: Identify and recruit postdoctordl trainees, junior faculty and mid-career faculty with potential to become leaders in geriatric/gerontologic research. Provide salary support and financial support to attend educational activities locally and nationally. Provide structured mentoring in the individual's discipline and in interdisciplinary research, with structured ongoing evaluation of progress. Facilitate access of UTMB OAIC trainees to OAIC core resources at UTMB and at OAICs at other institutions. Facilitate access of UTMB OAIC trainees to OAIC educational programs at UTMB and at other institutions. Facilitate access of trainees from OAICs at other institutions to UTMB core resources and educational programs. Coordinate training and educational experiences across all the UTMB OAIC cores and integrate relevant non-OAIC UTMB training experiences. Our goal is to provide an integrated training program in which junior faculty acquire capabilities in research program development and management, scientific communication, professionalism and leadership in science, and translation of research findings to effective interventions.